Brain pathologies, reserve and cognition in aging and dementia

DESCRIPTION (provided by applicant): This study seeks to better understand the relationship of brain pathology to cognitive function in aging and dementia. There is striking variability in how individuals' mental abilities change with age; some people change little, if any, others have major, debilitating drops. Why, is unknown. One explanation is brain pathologies such as Alzheimer's disease (AD) and infarcts (strokes). AD, which is the predominant cause of dementia, develops slowly and may actually begin to appear in brain decades before overt symptoms are appear. Some degree of AD changes and vascular disease is present in most very old people. However, studies that relate pathology to cognitive function generally fail to explain most of the variance. One potential reason may be that the pathology has been inadequately measured. Alternatively, it may be that brain pathology, no matter how exquisitely measured, will never explain cognitive losses adequately because of factors that moderate the impact of pathology. This explanation has been developed in the concept of reserve, the idea that some set of innate and acquired characteristics form a buffer that provides a degree of protection against the impact of brain pathology. It is a concept that holds enormous potential importance for public health because it suggests that, to the degree these factors are modifiable, people can take steps to substantially protect themselves against a broad array of common and debilitating brain conditions. We propose to measure cerebral pathology better than has been done previously, to model the effects of pathology on cognitive function, and then to use these improved models to better understand the role of reserve as a moderator of the impact of brain pathology. A major barrier to previous investigation has been the inability to measure the presence of Alzheimer's disease during life. The recent development of tracers for beta amyloid (an abnormal protein fragment critical in AD) changes this. We will use PET with the tracer Pittsburgh B (PIB) to quantify the extent of cerebral amyloid, and will obtain MRI measures of structural brain pathology (atrophy, infarcts and white matter lesions) and thus model the joint effects of the two major age- associated pathologies on cognitive function. We will then use the results of that effort to study reserve. We will do so in an ethnically diverse sample that has a wide range of education, which is generally thought to be a marker for reserve, and will use neuropsychological tests with superior measurement properties. Thus we will be able to characterize brain pathology levels during life better than has ever been done before and relate those findings to cognitive function that is measured especially well across a broad spectrum of putative reserve. PUBLIC HEALTH RELEVANCE: This project focuses on how pathology affects mental function and on the notion that reserve may buffer these effects. Reserve is a concept that holds enormous potential importance for public health because, to the extent reserve is based in lifetime experiences-cognitively stimulating activities, for example-- it suggests that people can take steps to protect themselves against a broad array of common and debilitating brain disorders.

Public health relevance
PROJECT NARRATIVE This project focuses on how pathology affects mental function and on the notion that "reserve" may buffer these effects. Reserve is a concept that holds enormous potential importance for public health because, to the extent reserve is based in lifetime experiences-cognitively stimulating activities, for example-- it suggests that people can take steps to protect themselves against a broad array of common and debilitating brain disorders.